Protective Role of Mitochondrial CHCHD10 in Alzheimer's Disease through MAM and Mitophagy Mechanisms.

Project Summary
Dysfunctions in mitochondria and mitochondria-associated endoplasmic reticulum (ER) membrane (MAM) are
associated with the accumulation of amyloid β (Aβ) and hyperphosphorylated tau in Alzheimer's disease (AD).
Mitochondrial protein, CHCHD10, plays a pivotal role in governing various mitochondrial functions, including
respiration, genome stability, dynamics, cristae organization, and oxidative phosphorylation. In our preliminary
study, CHCHD10 declines in the brains of APP/PS1 mice and human AD patients, which negatively correlates
with Ab levels. Restoration of CHCHD10 in APP/PS1 mice reduces AD pathogenesis in vivo. In transfected cells,
wild-type CHCHD10 promotes mitochondrial respiration as well as mitophagy and autophagy via PINK1/Parkin
and p62/LC3 pathways. In addition, increasing CHCHD10 mitigates MAM hyperactivity in AD. We have identified
specific small DNA oligos (antagoNATs) derived from CHCHD10 natural antisense transcripts (NATs) that
effectively augment CHCHD10 levels in both mouse and human cells. Our preliminary study shows that
CHCHD10 antagoNATs increase endogenous CHCHD10 protein both in vivo in mice brains and in vitro in human
cell lines. This study has two principal objectives: (1) to evaluate the therapeutic potential of CHCHD10
antagoNATs by assessing their protective effects on these phenotypes in APP/PS1 mice and human neurons,
and (2) to delineate the intricate interplay between CHCHD10, MAM, and mitophagy, thus elucidating their
collective role in ameliorating AD pathogenesis.
Successful conclusion of this study will: (1) facilitate the CHCHD10 antagoNATs as a therapeutic strategy for
AD; (2) provide a mechanistic basis and insights into CHCHD10-associated mechanisms in AD.

Public health relevance
Project Narrative Mitochondrial dysfunction, mitophagy deficits, and the hyperactivity of mitochondria-associated ER membranes (MAM) are early and causative events in the pathogenesis of Alzheimer's disease (AD). The aim of this proposal is to investigate the mechanism underlying the regulation of mitophagy/autophagy and MAM activity by mitochondrial CHCHD10 and to validate the protective role of CHCHD10 antagoNATs in AD pathogenesis in the brains of AD animal model and human neurons.